Regulation of endogenous genes by sexually dimorphic piRNA expression during germline development in C. elegans

PROJECT ABSTRACT
Small RNAs – short, noncoding RNAs – are critical regulators in animal physiology and disease that silence
gene expression by complementary base pairing interactions to control mRNA stability/translation and epigenetic
modifications. Small RNA-mediated silencing pathways are evolutionarily conserved, and the largest class of
small RNAs comprise Piwi-interacting RNAs (piRNAs). Extensive studies in fly established that piRNAs silence
transposons and are expressed in a sex-specific manner; piRNAs are essential for genome integrity and
germline development. However, most piRNAs in mammals and worm do not map to transposons, and instead
are predicted to regulate germline-expressed genes. Although novel associations of individual piRNAs with
endogenous genes have been reported, endogenous gene targets of piRNAs remain largely unknown.
In C. elegans, each of the ~15,000 piRNAs is autonomously transcribed and contains an upstream cis-
regulatory element, the Ruby motif. We found piRNAs are differentially expressed during spermatogenesis and
oogenesis, and male piRNAs have a strong bias for the 5’C nucleotide in the Ruby motif. Furthermore, we
identified SNPC-1.3 as a sex-specific transcription factor critical for male fertility. SNPC-1.3 depends on a known
core piRNA biogenesis factor, SNPC-4, to drive male piRNA expression during spermatogenesis. Loss of snpc-
1.3 during spermatogenesis results in global depletion of male piRNAs and sperm maturation defects. Other
piRNA biogenesis factors have been identified, but how these trans-acting factors interact with each other and
the Ruby motif is poorly understood.
In this proposed research, I hypothesize that sex-specific regulatory mechanisms underlie piRNA
expression to regulate endogenous genes critical for proper germline development. To test my hypothesis in the
context of spermatogenesis, in Aim 1 I will use a recently developed strategy Cleavage Under Targets and
Release Using Nuclease (CUT&RUN) to characterize protein-DNA binding profiles of 5 piRNA biogenesis trans-
acting factors at the Ruby motif cis-regulatory element. Furthermore, I will determine if the 5’ C nucleotide in the
Ruby motif acts as a male specific element for SNPC-1.3. I will also use computational tools to identify putative,
novel cis-regulatory elements for male and female piRNAs. In Aim 2, I will computationally identify endogenous
gene targets of male piRNAs from small RNA-seq and mRNA-seq in wild-type and snpc-1.3(-) animals as well
as piRTarBase, a database of computationally predicted and experimentally identified piRNA targeting sites. I
will experimentally validate male piRNAs and their predicted endogenous gene targets using reporter assays for
endogenous and synthetic piRNAs and applying CRISPR/Cas9-mediated mutagenesis of piRNAs or their
targets. Collectively, this research will strengthen our understanding of how sex-specific piRNA expression is
transcriptionally regulated and provide new insights into biological roles of piRNAs beyond transposon silencing.

Public health relevance
PROJECT NARRATIVE PIWI-interacting RNAs (piRNAs) are expressed in a sex-specific manner across many species, including human. Understanding how sex-specific piRNA expression regulates germline gene expression is paramount to advancing our knowledge of piRNA-mediated regulation beyond transposon silencing and improving therapeutic strategies for infertility. Using C. elegans as a model, the proposed research will define regulatory machinery underlying sex-specific piRNA expression and identify endogenous gene targets of piRNAs to provide a deeper understanding of piRNAs in germline development.